Identification of Age and Injury Dependent Mechanisms of Elastic Fiber Dynamics in the Murine Vagina

Project Summary
The average age of first-time mothers in the United States is increasing, and this delay can have deleterious
effects on maternal health since pregnancies after the age of 35 have a 350% greater risk of obstetric injury.
Furthermore, maternal age at the time of delivery is associated with increased risk of pelvic organ prolapse
(POP) which is defined by the abnormal descent of the female pelvic organs due to impaired structural integrity
of the pelvic floor and vagina. Treatment for POP typically involves surgery to restore normal anatomy, however
one-in-three POP reconstructive surgeries will fail because they utilize native tissue that is degraded due to age
or injury. While age and vaginal parity are leading risk factors for POP, the fundamental mechanisms linking age,
injury, and postpartum healing to pelvic floor stability remains unknown. This lack of mechanistic understanding
has slowed the development of effective non-surgical therapies for treating conditions of the pelvic floor. Towards
this end, our data shows that vaginal compliance and contractility decrease with age in non-pregnant mice as a
result of compromised elastic fiber functionality. We have also shown that surgical injury exacerbates disruption
of the vaginal elastic fiber network, which in turn contributes to impaired vaginal wound healing. Taken together,
these observations suggest functional elastic fibers are important for preserving vaginal integrity and postpartum
healing potential with age and injury and may be an important biological target for improving pelvic floor stability.
This led us to explore potential therapeutic approaches to induce elastic fiber synthesis. To this end, the anti-
hypertensive drug minoxidil has shown beneficial effects on elastin production in blood vessels but had not been
investigated in pelvic floor tissues; our initial observations suggest minoxidil induces both ex vivo elastin
synthesis in cultured murine vaginal explants and in vivo vaginal elastic fiber deposition following local injections.
Given these promising findings, and the importance of elastic fibers in vaginal stability, the current proposal will
1) determine which vaginal cells produce elastin during postpartum healing and if production is constrained by
age or injury, 2) demonstrate the spatiotemporal dynamics of functional elastic fibers with and without vaginal
injury, and 3) evaluate the efficacy of minoxidil to ameliorate deleterious changes in the vaginal wall with age
and injury. In Aim 1 we will determine injury-dependent mechanisms of elastic fiber dynamics in the murine
vaginal fibromuscular layer, and in Aim 2 we will elucidate if age is a key determinant of functional elastic fiber
dynamics and vaginal healing potential. We expect to demonstrate that elastic fibers are produced by fibroblast-
like cells and that age and injury decrease functional elastic fiber production. We also expect to reveal minoxidil’s
ability to generate de novo functional elastic fibers and improve healing potential after treatment as a result of
increased biomechanical stability. This work will evaluate a first-of-its-kind minimally invasive biological treatment
to prevent or halt deleterious elastic fiber remodeling of the murine vaginal fibromuscular layer. We expect these
results will be applicable for the treatment, or even prevention, of pathologies such as POP and vaginal atrophy.

Public health relevance
Project Narrative As a result of nine times more women delaying childbearing compared to several decades ago, the increase in average maternal age at the time of first pregnancy has become a primary risk factor for obstetric injury and pelvic organ prolapse. Although the cellular and molecular mechanisms that predispose advanced maternal age women to such complications are not well understood, observational studies have identified that elastic fibers are both critical for pelvic floor stability and diminished with age, injury, and prolapse. Here we will characterize the cellular and molecular drivers of postpartum vaginal elastic fiber dynamics and test the hypothesis that the loss of functional elastic fibers with age and injury impairs vaginal structural integrity while showing that a pharmacologic approach to increase elastic fiber synthesis can mitigate deleterious remodeling and provide a first step toward non-surgical treatment of structural disorders of the pelvic floor.